Emory Psychiatry Clinical Scientist Training Program (CSTP)

Project Summary
The Emory Psychiatry Clinical Scientist Training Program (CSTP) is designed to address critical shortages in
well-trained physician scientists pursuing a career in research, while increasing access to research training and
experiences for all residents. The Institute of Medicine deemed that sustaining and nurturing research interests
of residents is vital to the future of psychiatry research.
This renewal of the Emory CSTP will continue to address critical gaps in research training for psychiatry
residents through four specific aims that leverage our previous successes, while building on lessons learned.
In AIM 1, we will continue to recruit, train and retain highly qualified physician-scientists and provide
protected time for intensive mentorship, didactics and individualized research experiences dedicated to
fostering an independent career in mental health research. Training will emphasize fundamentals in research
design, data analysis and computational methods, manuscript and grant preparation, presentation skills, rigor
and reproducibility and ethical conduct of research. In AIM 2, we will continue to provide an enhanced
research curriculum for all psychiatry residents through didactics and small-group experiential learning
activities including our “Particle to Professor” seminar series and opportunities for all psychiatry residents to
participate in CSTP research activities. In AIM 3, we will strive to increase the diversity of our program by
adding a Diversity Committee that will advise on strategies to attract and match applicants of diversity. We will
also launch a pilot program with the Department of Psychiatry and Behavioral Sciences at Morehouse School
of Medicine to increase residents from diverse backgrounds in the Emory CSTP and facilitate Morehouse's
development of their own research track. In AIM 4, we will establish a platform for ongoing collaboration
with other R25 programs and the NIMH to establish and disseminate best practices for achieving the goal of
increasing the number of physician scientists who successfully pursue a career in mental health research.
The overarching objective of the Emory CSTP is to continue to provide enhanced research training for
all residents in psychiatry, while providing specialized mentored research training opportunities for residents
poised to become physician-scientists. The proposed program emphasizes proactive engagement and novel
mentored research opportunities through internet-based strategies, experiential research learning activities,
mentorship throughout residency and exposure to innovative research faculty and research programs in areas
including neuromodulation, the neurobiology of fear and trauma-related disorders, behavioral immunology and
endocrinology, neurodevelopment, translational social neuroscience, community psychiatry and public health.
Given a solid research training base, ongoing faculty support, mentorship, and independent research
experiences as well as specialized research training, CSTP research track residents will be well-equipped to
pursue academic careers, working to solve the most pressing problems in psychiatry.

Public health relevance
Project Narrative Addressing the significant mental health burden of our modern society cannot be accomplished in the absence of meaningful scientific discovery by physician-scientists. The Emory Clinical Scientist Training Program (CSTP) addresses the critical shortage of well-trained physician-scientists in psychiatry by utilizing an innovative research training platform, grounded in state-of the-art clinical neuroscience research and addressing the primary need for intensive mentorship throughout psychiatry residency. In addition, the Emory CSTP provides research training and experiences to all psychiatry residents to nurture their interests in research and prepare them for a life-long practice of evidence-based medicine.